Pathogenesis Studies Of Simian Immunodeficiency Virus

An experimental animal model in which the course of immunodeficiency virus infection parallels the pathogenesis of the human disease is critical for the study of human AIDS. Simian immunodeficiency virus (SIV) infection of macaques satisfies this criterion and is therefore a relevant model. SIV induces an immunodeficiency syndrome in infected macaques that is remarkably similar in pathogenesis to human AIDS. An important use of this animal model system is the detailed study of pathogenesis and viral determinants of disease since many studies of this type are not feasible in humans. Such investigations should allow us to determine how primate lentiviruses destroy the immune system of their hosts, and facilitate the development of more rational therapeutic antiviral strategies. The purpose of this project is to investigate host and viral factors involved in variable disease progression in SIV-infected macaques and the lack of disease in African primates infected with their own strains of SIV. PATHOGENESIS OF SIVsm-INFECTION OF MACAQUES: To investigate the role of host factors in SIV-infection of macaques, we used well-a defined molecularly cloned virus (SIVsmE543-3). Initial studies demonstrated that susceptibility to SIV infection of primary PBMC in vitro varies significantly between individual macaques. Interestingly, the susceptibility phenotype correlates with the extent of in vivo viral replication following inoculation of these animals. A cohort of six rhesus macaques with a wide range of susceptibility phenotypes were inoculated with SIVsmE543. Susceptibility of PBMC in vitro was highly predictive of subsequent viremia. We evaluated the immune responses, both SIV-specific and to unrelated antigens in macaques that progress rapidly to AIDS in under 6 months. Four rapid progressors (RP) from three separate studies were evaluated for antibody and CTL responses. These animals developed transient CTL and antibody responses. RP macaques immunized with tetanus toxoid and Hepatitis A (Haverix) to evaluate their ability to respond to memory and recall antigens failed to develop antibody to either antigen, consistent with a global immune defect. In collaborative studies with the Martin laboratory, the phenotype of CD4+ T cells was compared in SHIV-infected and SIVsmE543-3-infected macaques. Whereas SHIV-infection resulted in depletion of CXCR4+ naive CD4+ T cells, SIVsmE543-3-infecetd RP macaques showed profound and early depletion of memory CD4+ T cells explaining the profound immune deficits in these animals. To characterize viral factors involved in pathogenesis, virus from RP macaques was molecularly and biologically characterized. Sequence analysis of env genes cloned from three SIVsm-infected animals exhibited common substitutions in the env gene. These substitutions were unusual in that they involved residues that were generally conserved and that were known to affect binding of env to CD4 or coreceptor.The majority of envelope genes from such rapid progressor macaques utilize CCR5 as a receptor in the absence of CD4. Full length infectious molecular clones of various RP viruses were derived from plasma of RP RhH635. These viruses use CCR5 as a coreceptor and replicate less efficiently in primary macaque PBMC and macrophages than the parental SIVsmE543-3 strain. Studies are ongoing to evaluate their pathogenicity in naive Rh macaques. Previous studies in this lab demonstrated that infection of PT macaques (Macaca nemestrina) with one isolate of SIVagm results in AIDS. This virus was passaged in a PT macaque and thus might not be entirely reflective of the virulence of the parental strain. We assessed the pathogenicity of the PT-passaged isolate (SIVagm9063) and two primary SIVagm isolates in PT macaques, including the parental strain of the PT-passaged variant. Infection of macaques with any of the three isolates resulted in high levels of primary plasma viremia by 1 week after inoculation. Viremia was quickly controlled following infection with SIVagm155; these animals have maintained CD4+ T cell subsets and remain healthy. The plateau levels among SIVagm90 and SIVagm9063-inoculated macaques varied widely from 100 to a million copies/ml of plasma. Three of four animals from each of these groups progressed to AIDS. Setpoint viremia and the degree of CD4+ T cell loss at 6 months post infection were not significantly different between macaques inoculated with SIVagm90 and SIVagm9063. However these parameters were significantly different in SIVagm155-inoculated macaques. The degree of CD4+ T cell loss by 6 months post infection correlated with the plateau levels of viremia. Thus, similar to SIVsm/mac-infection of macaques and human AIDS, viral load is an excellent prognostic indicator of disease course. Previous studies in this laboratory showed that the related SIVlhoest and SIVsun strains are capable of inducing AIDS in PT macaques. Longterm follow-up of these animals demonstrated profound CD4+ T cell depletion. Although these animals exhibited high levels of primary viremia, progression to AIDS occurred despite moderate to low chronic viremia suggesting other mechanisms than direct virus-induced cell killing in the pathogenesis of this infection. ASYMPTOMATIC INFECTION OF NATURAL HOST SPECIES A secondary goal of this project is to study the mechanisms underlying the apparent lack of pathogenicity of SIV for their natural host species, with emphasis on SIVagm from vervet monkeys. SIVsm, SIVagm and SIVlhoest are capable of inducing AIDS in macaques but are not virulent for their natural host. These studies have utilized a molecularly cloned, pathogenic SIVagm9063-2 that induces AIDS in pigtailed macaques but results in asymptomatic infection of African green monkeys. Natural and experimental infection of vervets (Chlorocebus pygerythrus) with SIVagm was evaluated by in situ hybridization, plasma viral load and limiting dilution coculture to identify the numbers and distribution of infected cells in tissues. Virus was found in lymphoid tissues and the gastrointestinal tract and in the lung macrophages of one animal. Plasma viral load varied from undetectable (<1000 copies/ml) to 800,000 copies/ml. We recently expanded these studies by evaluating plasma viremia in a cohort of 12 naturally infected vervets from Tanzania. Plasma viral load varied from 1000 to >100,000 copies/ml. these animals. PCR and sequence analysis of portions of the envelope gene of these novel SIVagm isolates revealed wide genetic diversity, although all isolates clustered phylogenetically with previously characterized SIVagm isolates from vervets, confirming that these source animals were indeed vervet AGM. The kinetics of viremia of one of these viruses in naive vervets was evaluated in a pilot experiment using intravenous inoculation of blood from one naturally-infected donor, AG1. These animals exhibited high levels of primary viremia with a similar setpoint range as observed in the naturally-infected cohort. These animals have remained asymptomatic for 1 year of follow-up. We evaluated the viral kinetics of a natural SIVagm isolate in AGM. Two species of AGM were evaluated, vervet monkeys (the species of origin of SIVagm90) and sabaeus monkeys from the Barbados. The virologic outcome in sabaeus and vervet AGM was surprisingly divergent. Inoculation of sabaeus AGM with SIVagm90 resulted in low and variable levels of primary viremia and low setpoint. In contrast, inoculation of vervet AGM resulted in high primary viremia and establishment of moderate plateau levels. Regardless of the extent of viremia, CD4+ T lymphocytes remained stable throughout infection of AGM with no significant relationship between viral load and CD4+ T cell loss.